Cancer Undergraduate Research Education Program

ABSTRACT
Cancer disproportionately affects Black Americans and other economically disadvantaged groups, yet these
individuals are underrepresented in cancer research. The Cancer Undergraduate Research Education Program
(CUREP) proposes to address this disparity by expanding and diversifying the pool of future cancer researchers
within the biomedical workforce. Our objective is to create a summer undergraduate research program in
collaboration with the University of North Carolina, Chapel Hill (UNC-CH), North Carolina Central University
(NCCU), and North Carolina A & T University (NCAT), two historically Black universities. CUREP aims to admit
12 undergraduates from underrepresented groups (URGs) each year, focusing on first-generation college
students, those from economically and socially disadvantaged backgrounds, and those with limited prior
research experience. The program has three specific aims: 1) Provide URG students with hands-on experience
in cancer research during a ten-week summer internship. 2) Increase student interest in pursuing careers in
cancer research by offering professional development activities essential for gaining admission to graduate and
professional schools. 3) Provide year-long group coaching (covering summer, fall, and spring) to help students
integrate academic and life skills and increase their chances of successfully completing their degrees. CUREP
offers participants opportunities to expand their knowledge, explore various aspects of cancer research, and
develop the skills needed for successful careers in cancer research. The program's key components include
direct research experience under the guidance of principal investigators conducting cancer research. These
faculty mentors come from diverse backgrounds, including URGs, and possess expertise in basic cancer biology,
population science, translational cancer research, and cancer disparities. Our program's structure builds upon a
previously funded NIH U54 partnership educational program, Partners, focused on cancer health disparities
between UNC and NCCU (NCI U54 CA156735). Though about two-thirds of Partners alums are pursuing
advanced degrees, students face challenges in various aspects of their lives. Our innovative approach integrates
academic study with life skills coaching, creating a comprehensive program to prepare young scientists for future
challenges. Students will conduct independent research under the supervision of PI mentors, graduate students,
and postdocs in laboratories or research teams specializing in population science. Their research experiences
will be complemented by training in ethics and various professional and career development activities,
culminating in research presentations at the end of the summer. A distinguishing feature of CUREP is its year-
long coaching component, encompassing study skills, academic writing, time management, self-efficacy, career
planning, and wellness. This holistic approach enables participants to integrate academic and social/life skills
effectively. Ultimately, CUREP aims to increase the participation and representation of URGs in cancer research,
contributing significantly to the diversification of the biomedical workforce.

Public health relevance
PROJECT NARRATIVE Black Americans and other underrepresented groups (URGs) face a disproportionate cancer burden, yet racial and ethnic diversity in the biomedical workforce lags behind, including cancer research. The Cancer Undergraduate Research Education Program (CUREP) offers a distinctive ten-week program with hands-on cancer research, professional development, and year-long academic coaching to underrepresented students from a predominantly White university and two Historically Black Colleges and Universities (HBCUs), aiming to prepare them for careers in biomedical cancer research. Ultimately, CUREP's long-term goal is to enhance URGs' participation, representation, and impact in cancer research, thus significantly contributing to expanding diversity in the biomedical workforce.